2024 International Colloquium on Hyperemesis Gravidarum

This application seeks funding to support attendance and presentation by those who are trainees, new
investigators, or under-represented minorities at the 2024 International Colloquium on Hyperemesis
Gravidarum. Hyperemesis gravidarum (HG) is a severe form of nausea and vomiting during pregnancy
that affects approximately 3-10% of pregnant women, leading to significant short- and long-term
complications for both the pregnant patient and fetus. Minority populations and their offspring are
disproportionately affected. This conference is designed to foster collaboration between researchers,
clinicians, patients, and patient advocacy groups to further our understanding and improve the
treatment of HG. We will be highlighting new research on the pathogenesis of HG with opportunities
for treatment and prevention, the impact of malnutrition and strategies to prevent it, HG challenges in
low-income nations, the need for further research on health disparities, and improving equity in the
treatment of patients with HG. This will be the 5th biennial international conference on HG, but the first
held in the United States. The meeting will be held over 2 days with multiple opportunities for oral and
poster presentations including new investigators. Prizes will be awarded for the best oral and poster
presentations by trainees. There will be breakout sessions designed to foster collaboration between
experienced researchers and new investigators along with clinicians and patients. Attendees and
presenters will be able to apply for travel support and recipients will be chosen by the ICHG Scientific
Committee based on their expressed need, contribution(s) to the meeting, trainee/new investigator
status, identification as a member of an underrepresented minority, and/or individual with a disability
or residence in a developing country. ICHG historically has a high representation of women as both
speakers and attendees (>50% speakers, >75% attendees). Minority representation has been low, so we
are striving to improve representation. This grant will help to improve diversity and several sessions
will help promote more inclusive research and better equity in patient care. Our selected venue will be
compliant with the Americans with Disabilities Act. There are many family-friendly activities available,
and childcare options will be identified and distributed to participants. Breastfeeding infants are
welcome in the meeting, and a private room made available for breastfeeding. The result of the
conference will be much-needed progress toward advancing collaboration, research, education, equity,
and ultimately improved care and outcomes for this devastating pregnancy condition.

Public health relevance
The purpose of this conference is to disseminate research findings, discuss treatment strategies, and foster further research into the condition hyperemesis gravidarum (HG). HG is a top cause of hospital visits during pregnancy and contributes to maternal and fetal mortality and complications including preeclampsia, preterm delivery, persistent mental health disorders (including postpartum depression and post-traumatic stress disorder), fetal growth restriction, abnormal brain growth, and child neurodevelopmental disorders. This conference will facilitate collaboration of researchers and clinicians from multiple disciplines, along with patients and patient advocacy groups, with the goal of advancing the understanding HG and its etiology, identifying patient needs, and developing strategies for improving care and outcomes.